VANDERBILT-VIETNAM TRAINING PROGRAM IN GENETIC EPIDEMIOLOGY

PROJECT SUMMARY
The objective of this training program is for Vanderbilt-Vietnam Genetic Epidemiology Training Program (V2-
GENE) will join efforts across Vanderbilt University (VU) and low-middle income country (LMIC) partners Hanoi
Medical University (HMU), and Vietnam National Cancer institute (VNCI) to train scholars in the genetic
epidemiology of NCDs. Non-communicable disease (NCD) is the leading cause of death globally, accounting
for about 71% of the 56.9 million deaths that occurred worldwide in 2016 and 74% in 2022. With a population
over 96 million, Vietnam ranks as the 14th most populous country in the world. Vietnam, a LMIC. The goal of
the program is to develop a team of researchers and educators prepared with the necessary training and
expertise to lead genetic epidemiology research of non-communicable diseases (NCD) across the lifecourse in
Vietnam and to enhance engagement of US-based researchers in low- and middle-income countries (LMIC).
We build upon existing partnerships across VU and HMU/NCI as well as the substantial expertise in genetics
and genomics research in NCD and research training in LMICs from investigators in the Vanderbilt
Epidemiology Center and the Vanderbilt Genetics Institute. We will leverage Vanderbilt’s robust and existing
infrastructure that provides training for faculty, postdoctoral fellows, and PhD graduate students to lead this
program. Integrating our training with these existing resources will ensure the success of the trainees
supported through our program. Specifically, the V2-GENE program seeks to: 1. Train leaders and trainers in
genetic epidemiology research. We will target three visiting faculty members from HMU and VNCI for one-year
appointments who have existing and complimentary expertise in epidemiology and molecular genetics
research. They will receive mentorship and grant writing training during their visit to VUMC. 2. Train scientists
and future leaders in genetic epidemiology research. This will be accomplished through combined US- and
Vietnam-based training activities (three predoctoral PhDs [three-year appointment], three MPH students [two-
year appointment], and one postdoctoral fellow [two-year appointment] from Vietnam) that include didactic
courses and mentored research activities. 3. Guide our training with activities that ensure a long-term impact.
Our approach of training the trainers and building training infrastructure within Vietnam will provide
sustainability for the program. The long-term follow-up of alumni will also foster collaborations and continued
support beyond the duration of the training period. Direct outcomes of this training program will be expanded
workforce and development of future leaders in genetic epidemiology research within Vietnam and further
engagement of US researchers in global health research. This synergistic partnership across VU and Vietnam
as part of the V2-GENE program will significantly enhance the research and training capacity for genetic and
genomics of NCD within Vietnam. This program will build the necessary workforce within Vietnam to lead the
next-generation of genetics researchers.

Public health relevance
PROJECT NARRATIVE Genetics and microbiome, and their interaction with a wide variety of exposures ranging play a critical role development and progress of non-communicable diseases (NCD) but there are limited genetic epidemiology research in Vietnam, due in part to a lack of existing infrastructure, an existing cadre of trained investigators, and funding. This proposed Vanderbilt University Medical Center (VUMC) and Vietnamese (Hanoi Medical University [HMU] and Vietnam National Cancer institute [VNCI]) partnership will expand upon our existing partnership to establish the new Vanderbilt-Vietnam Genetic Epidemiology (V2-GENE) Training Program focused on training student in the tools needed for genetic analysis of NCDs, across types of diseases. There is shortage of trained genetic epidemiologist in low-middle income countries (LMICs) trained in genetic epidemiology, our goals with V2-GENE are to equip educators and trainees with the skills in genetic epidemiology to engage in sustainable long-term research activities in genetic studies of lifecourse and non- communicable diseases and to further solidify the collaborations and partnerships across VUMC faculty within low- and middle-income countries.